Development of a Personalized Intervention to Motivate Health Behavior Change in Midlife Adults at Risk for Alzheimer's Disease

PROJECT ABSTRACT
Modifiable risk factors such as physical activity, healthy diet, stress reduction, and cognitive stimulation are
associated with lower risk of Alzheimer’s disease (AD) and related dementias. Population-level engagement in
positive health behaviors in midlife and early late life is low, and large, multi-domain prevention trials have
reported a positive impact of lifestyle modification on risk for cognitive decline. However, adherence to trial
protocols is poor despite intensive individualized coaching, raising concern about generalizability and the ability
to motivate sustained behavior change. The objective of this Stage I intervention development project is to use
the science of behavior change to develop a theoretically grounded, personalized health education intervention
that will motivate sustained health behavior change to prevent or delay the onset of Alzheimer’s disease (AD).
The intervention will be grounded in the Health Belief Model, a widely-used conceptual framework that posits
that health beliefs including perceived threat of disease, perceived benefits and barriers, and self-efficacy
(belief in one’s ability to change) are mediators of behavior change. The proposed project will enhance our
existing 12-session basic healthy living education program to include evidence-based assessment of health
belief factors and personalized education about the role these factors play in motivating and sustaining
behavior change. We will use qualitative methods to develop an explanatory method for communicating
personal health beliefs (Aim 1) and conduct a randomized controlled pilot trial to assess feasibility and the
effect of the enhanced intervention versus basic health education alone on proximal outcomes including AD
risk perception, self-efficacy, and AD risk knowledge (Aim 2). Results will motivate future efficacy studies
investigating the impact of the enhanced healthy living education intervention on distal outcomes, including
engagement in positive health behaviors, lower AD risk, and prevention of cognitive decline.

Public health relevance
PROJECT NARRATIVE Modifying health behaviors like physical activity level, diet, stress, and mental activity level can lower risk for Alzheimer’s disease, but many middle-aged and older adults find it difficult to sustain health behavior changes over the long term. This project will develop a new intervention that educates people about Alzheimer’s disease risk factors and helps them understand how their personal health beliefs may prevent them from making long-lasting lifestyle changes. The goal is to help people sustain health behavior changes to prevent or delay the onset of Alzheimer’s disease and related dementias.